Senior Leadership

The Rollings Cancer Center (HCC) is directed by Andrew S. Kraft, MD (Director) with the assistance of Anthony J. Alberg, PhD, MPH (Associate Director of Cancer Prevention & Control); Daniel J. Fernandes, PhD (Associate Director of Translational Research); Marvella E. Ford, PhD (Associate Director of Cancer Disparities); Yusuf A. Hannun, MD (Associate Director of Basic Sciences); Anita L. Harrison, MPA (Associate Director of Administration); Carolyn E. Reed, MD (Associate Director of Medical Affairs); Steven A. Rosenzweig, PhD (Assistant Director of Shared Resources); and Melanie B. Thomas, MD (Associate Director of Clinical Investigations). These experienced individuals are organized as a Senior Leadership team that represents the strong functional nexus of this matrix-based Center. Dr. Kraft has charged the members of the team with employing consensus building techniques as they work directly with the various HCC boards/councils and committees to formulate priorities, strategies and allocation of resources. The Senior Leadership team works together to ensure consistency in the vision and goals of the Center; develop synergistic interactions among the basic, translational, and clinical elements of the Center; plan proactive approaches to the development of the research base and resources; effectively leverage all available resources at MUSC and at the state and national levels; engage in community outreach; and oversee all activities of the HCC. The Senior Leadership team meets several times a month in the context of HCC's various board/committee/council meetings, one-on-one with the Director, and once a month as a formal Executive Council. They provide direct counsel and recommendations to the Director based on these interactions. All final authority for decisions on behalf of the HCC resides with the Director.

Public health relevance
Support is requested for several members of the HCC Senior Leadership who provide counsel and recommendations to the Director as it pertains to the strategic planning and evaluation of the Center's efforts.